Pathogenic role of a protein complex of liver origin as regulator of a proinflammatory program that drives hepatic and intestinal injury in alcoholic liver disease

ABSTRACT
Inflammation is a hallmark of alcohol-induced liver injury. Numerous studies established the role of the gut-to-
liver axis, but there is limited information on how the liver-to-gut axis contributes to inflammation and injury in
alcoholic liver disease. It is unknown whether ethanol-induced sterile damage-associated molecular patterns of
liver origin activate a proinflammatory program that, besides being detrimental to the liver, drive intestinal
barrier dysfunction, hence creating an amplifying proinflammatory feedback loop in alcoholic liver disease. Our
overarching goal is to dissect the pathogenic role of a protein complex of liver origin in regulating a
proinflammatory program that drives hepatic and intestinal injury in alcoholic liver disease.
In prior work, we demonstrated that high-mobility group box-1 (HMGB1) is a damage-associated molecular
pattern up-regulated in response to liver injury and participates in the pathogenesis of alcoholic liver disease.
Interestingly, HMGB1 undergoes oxidation only in hepatocytes, and serum levels of oxidized HMGB1
([O]HMGB1) are increased in alcoholic patients. Our preliminary data demonstrate that blocking the production
of [O]HMGB1 in hepatocytes or ablating an HMGB1 receptor (the receptor for advanced glycation end-
products, RAGE) in myeloid cells prevents inflammation, hepatic injury, intestinal barrier dysfunction and
alcoholic liver disease. We show that Kupffer cells and infiltrated macrophages are the main hepatic source of
IL1β. Importantly, we reveal that [O]HMGB1 forms a complex with IL1β. This complex binds RAGE in Kupffer
cells and macrophages to produce a proinflammatory program and increases gut permeability in alcoholic liver
disease.
These encouraging data suggest that a proinflammatory feedback loop initiated by this complex, could
exacerbate hepatic and intestinal injury in alcoholic liver disease. However, key mechanistic aspects of how
this complex promotes the pathogenesis of alcoholic liver disease remain to be elucidated: 1) whether this
complex is of liver origin; 2) whether it is a ligand for RAGE; 3) the signals this complex conveys in Kupffer
cells and macrophages to induce a proinflammatory program that exacerbates hepatic injury; 4) whether it
alters tight junction protein expression in intestinal epithelial cells and increases intestinal barrier dysfunction;
and 5) whether the proinflammatory program itself also contributes to intestinal barrier dysfunction.
We propose a conceptually novel framework of a liver-to-gut proinflammatory feedback loop in alcoholic liver
disease. Our central hypothesis is that this complex is of liver origin and binds RAGE in Kupffer cells and
macrophages to induce a proinflammatory program that exacerbates hepatic injury. By binding RAGE in
intestinal epithelial cells and/or by inducing the proinflammatory program, this complex alters tight junction
protein expression and increases intestinal barrier dysfunction. We will test this hypothesis by pursuing three
specific aims. In Aim 1, we will identify the complex as being of liver origin. In Aim 2, we will determine the
complex binding affinity for RAGE in Kupffer cells and macrophages and identify the signals through which the
complex induces a proinflammatory program that exacerbates hepatic injury. In Aim 3, we will determine if the
complex alters tight junction protein expression and increases intestinal barrier dysfunction by binding RAGE in
intestinal epithelial cells and/or by inducing the proinflammatory program. Therefore, targeting this complex
could have significant therapeutic potential.

Public health relevance
PROJECT NARRATIVE To date, there is no proven effective cure for alcoholic liver disease. The work proposed in this application will dissect the pathogenic role of a protein complex of liver origin as a central upstream regulator of a proinflammatory program that besides being detrimental to the liver, drives intestinal injury; hence, creating an amplifying feedback loop in alcoholic liver disease. The results from this project will benefit the design of new therapies for preventing or treating this devastating disease that affects many US Veterans and is currently on the rise.